Live imaging-based molecular dissection of a successful vertebrate RGC axonal regeneration program

While many interventions promote some degree of axonal regeneration in mice, we are still far
from translating this knowledge into therapies, and this may be in part because we have very
limited information as to how regeneration is accomplished in related vertebrate species that
successfully regenerate their damaged axons. This project is focused on trying to systematically
deconstruct how the frog Xenopus laevis recovers from axon injuries to retinal ganglion cells,
managing to reconnect those damaged axons and regain vision. This proposal largely uses a
new surgical optic nerve crush model and live imaging platform that we recently developed in very
young tadpoles. With this system, we have already demonstrated that central players in
conveying the injury signal back to the cell body, a pathway involving the gene Dlk, as well as
how axons are removed from the optic nerve, a pathway involving the gene Sarm1, are highly
similar in tadpoles as they are in mammals. However, in our studies we have some surprising
findings that, if we further understand them, have potential to move forward the field. These
findings include finding that the Dlk effect on regeneration does not go through the transcription
factor Jun, a role for Sarm1 in axon regeneration as well as degeneration, and studies that
implicate myeloid cells in the successful regeneration program, possibly acting downstream of
Sarm1. The proposal focusses on the intrinsic pathways of Dlk and Sarm1 in the first Aim, mainly
in tadpoles, though also validating results and searching for effector genes in adult frogs. In the
second aim, in also largely live imaging-based experiments, we will use novel transgenes and
varied genetic perturbations to parcel out the role of myeloid cells, including also searching for
effector genes. In contrast to these two highly mechanistic aims, the third technique development
aim moves to create a much more glaucoma-relevant axon injury model, while also optimizing
genetic and pharmacological screening, so that hopefully in the near future we will be able to carry
out very large unbiased screens in a glaucoma-relevant axon injury model which take full
advantage of the unique properties of the frog as an experimental model organism.

Public health relevance
While many interventions promote some degree of axonal regeneration in mice, we are still far from translating this knowledge into therapies, and this may be in part because we have very limited information as to how regeneration is accomplished in other vertebrate species that successfully do so. This proposal mainly uses a novel tadpole optic nerve crush procedure and novel live imaging platform as well as extensive genetic perturbations to dissect cellular and molecular mechanisms intrinsic to the retinal ganglion cells and immune cells which enable frogs to successfully regenerate their axons after injury, as well as propose to optimize assays to conduct future large-scale unbiased screens using this system. The studies will significantly advance our mechanistic understanding of how retinal ganglion cells can recover from axonal injuries, and hopefully this information will be translatable in the foreseeable future into therapies for axon injury diseases such as glaucoma.